Intersection of Obesity and Heart Failure with Preserved Ejection Fraction

This project will elucidate the biological mechanisms by which obesity alters the myocardium in patients
with heart failure and a preserved ejection fraction (HFpEF) to ultimately derive sorely needed precision-
guided therapies. HFpEF currently represents more than half of all heart failure worldwide, its prevalence
is rising, morbidity and mortality are substantial, and yet we still have very few effective therapies. It is a
major unmet medical need and a disease priority for the NIH. One of the factors that has made it difficult to
treat is a major transformation over the past two decades such that most patients are now obese, many
severely, with diabetes and metabolic syndrome also very common. This obesity-metabolic syndrome
(OMS-HFpEF) phenotype has altered disease manifestations and progression and worsened prognosis.
Yet our knowledge of the underlying myocardial pathobiology effects from obesity are limited. Johns
Hopkins has established a dedicated clinical HFpEF Center that obtains detailed phenotyping of HFpEF
patients, the majority being OMS-HFpEF, African American, and female. The phenotyping includes
obtaining myocardial biopsies that have already provided novel insights into cellular and molecular
features. Our recent studies revealed less fibrosis than predicted, and that fat metabolism and glucose
metabolism seem both to be depressed in OMS-HFpEF, pairing abnormalities found in HF with reduced EF
and obesity/diabetes respectively, in essence a worst of both worlds that limits fuel flexibility. Yet unlike
HFrEF, oxidative phosphorylation seems enhanced particularly in obese patients. We also find a strong
inverse correlation between obesity and calcium-stimulated myofilament function – being very depressed in
OMS-HFpEF ± diabetes, hypertension, or LV hypertrophy. Obesity is thus a major driver for fundamental
changes in HFpEF. This R35 Program dissects metabolic and sarcomeric dysregulation in OMS-HFpEF,
starting with analysis of human myocardial tissues, and testing abnormalities in animal models that have
both marked OMS and cardiac hemodynamic stress. Models are benchmarked to pair with human
molecular/cellular pathobiology, rather than only organ level physiology as historically done. Our metabolic
studies will determine the fuel substrates used by OMS-HFpEF heart, where bottlenecks in fuel metabolism
occur, how these maybe circumvented and what the impact is, which metabolites are formed that can
impact epigenetics (histone modifications) to alter gene programs controlling metabolism and other key
cellular functions. Major interest is on Krebs cycle intermediates such as citrate, succinate and fumarate
and polyamines, that can impact histone methylation and acetylation. Our myocyte studies will determine
how obesity depresses sarcomere function, find the protein(s) and structural changes involved, their
causes, and prove causality. Lastly, we will test therapies to improve metabolic flexibility and sarcomere
performance in OMS-HFpEF that can lead to precision-guided medicines for this common phenotype.

Public health relevance
Heart failure with preserved ejection fraction affects a majority of heart failure patients, its prevalence is rising, and there are few effective therapies. Most patients today are also very obese, and this has altered the syndrome, worsening its prognosis and underlying pathobiology. This program elucidates how obesity has changed HFpEF at fundamental biological levels, including heart metabolism, gene expression and epigenetics, regulatory proteins, and the motors that make hearts contract.